A Novel Approach to Crack Neuronal Mechanisms that Shape Computations in the Brain

Project Summary
Living in this ever-changing environment, we continually adapt and learn new behaviors. The computation
mechanisms in our brain must be highly plastic to support such flexibility. Problems with this adaptive process,
on the other hand, result in inflexible and maladaptive behaviors, the main symptoms of Attention-Deficit /
Hyperactivity Disorder (ADHD), Obsessive-Compulsive Disorder (OCD), and other brain disorders. The goal of
this proposal is to establish an experimental method to approach what neuronal substrates and mechanisms
support our flexible behavior.
Neuronal computations are mediated by coordinated activity patterns across neurons, referred to as neuronal
dynamics. When we learn/adapt behavior, underlying neuronal dynamics change. This reconfiguration of
neuronal dynamics is constrained by synaptic interactions among neurons. Thus, changes in synaptic
interactions, or synaptic plasticity, likely mediate the shaping of neuronal dynamics and behavior. Therefore,
neuronal dynamics and synaptic plasticity are two pillars of brain functions that cooperate to flexibly adapt
behaviors. Yet, dynamics and plasticity have rarely been studied together due to the lack of appropriate
behavioral paradigms and experimental methods to examine them. To bridge this gap, I have established a novel
behavioral paradigm along with a proposal for a molecular screening method to identify the brain areas where
synaptic plasticity is responsible for adapting actions. Electrophysiological recordings at such brain areas
combined with manipulation of plasticity will allow us to crack a causal relationship between plasticity and
neuronal dynamics: we will identify what kinds of changes in neuronal dynamics are induced by synaptic plasticity
and how those changes result in improved behavior. By combining molecular, systems, and theoretical
neuroscience methods, our experimental approach will link plasticity, dynamics, and behavior to explain the
algorithmic basis of flexible computations in the brain.
Identifying neural substrates controlling flexible behaviors provides a foundation for examining how dysfunctions
of such substrates result in maladaptive behaviors observed in various brain disorders. Our novel approach to
combine electrophysiology with manipulations of plasticity has the potential to become a new standard in
neuroscience; and, linking neuronal dynamics and plasticity may inspire novel methods in machine learning and
artificial intelligence. Thus, our findings and unconventional approach will have a broad impact in neuroscience
and beyond.

Public health relevance
Project Narrative Our brains have an amazing flexibility to adapt and learn new behaviors. I will establish a novel behavioral paradigm and experimental methods, linking molecules, neuronal activity, and behavior, to identify brain areas and neuronal computations underlying such flexibility. Our findings will provide a neurobiological basis to explain how dysfunction in adaptive learning processes results in maladaptive behaviors observed in ADHD, OCD and other brain disorders.